Computational modeling of dynamic causal brain circuits underlying cognitive dysfunction in Alzheimer's disease

Project Abstract
Alzheimer’s disease (AD) affects over 5.7 million Americans and is expected to rise to nearly 14 million people
by 2060, as the number of people living with this disease doubles every 5 years. AD is a progressive and
severely debilitating disease that negatively affects cognitive and memory function and is linked to increased
disability in everyday functioning and risk of mortality. Neurodegeneration of focal brain areas in AD
progressively impacts large-scale brain circuits, leading to significant cognitive and behavioral impairments.
However, little is known regarding aberrant context-dependent dynamic causal interactions between
distributed brain regions, and their links to cognitive and memory impairments and neuropathology,
across AD clinical stages. Leveraging a productive and high-impact line of research in the current project
period, we now propose to address critical gaps in our knowledge of functional circuit mechanisms underlying
cognitive dysfunction in AD using innovative computational tools. Our first major goal is to continue to
address critical unmet needs in human brain research by developing and validating novel computational tools
for identifying context-dependent dynamic causal interactions between distributed brain regions. Building
on progress in the current project period, we will further develop novel Multivariate Dynamic Systems
Identification-Hamiltonian Monte Carlo techniques taking advantage of recent advances in Bayesian modeling
and inferencing. Our computational tools will be validated using optogenetic stimulation with whole-brain
fMRI, and stability analysis of normative Human Connectome Project data. Our second major goal is to use
MDSI-HMC to investigate aberrancies in dynamic causal circuits underlying cognitive and memory
impairment in AD. Our system neuroscience approach will target four key brain systems implicated in AD:
default mode network, medial temporal lobe, and two frontal control systems anchored in the frontoparietal and
salience networks. To achieve our goals, we will leverage clinical, phenotypic, cognitive, experimental, and
state-of-the-art fMRI, and beta amyloid (Aβ) and tau PET, data from multiple NIH-funded AD-specific
Human Connectome Projects. Our proposed studies will advance foundational knowledge of cognitive and
memory-related circuits across AD clinical stages and their links to neuropathology. More generally, our
proposed studies will also contribute novel tools for examining dynamical causal circuits underlying human
brain function and dysfunction. The proposed studies are highly relevant to the NIH Focus on AD and PAR-
10-070 which call for innovative characterization of functional brain circuits altered in AD. More broadly,
the proposed studies are relevant to the mission of the NIH to encourage development and dissemination of
innovative advanced computational tools for clinical neuroscience. We will disseminate our algorithms and
software tools to the research community as we have done in the current project period.

Public health relevance
Project Narrative Alzheimer’s disease (AD) affects over 5.7 million Americans and is expected to rise to nearly 14 million people by 2060, as the number of people living with this disease doubles every 5 years. Cognitive and memory impairments are a defining characteristic of AD and are thought to arise from dysfunctional circuits spanning multiple brain areas. Our proposed studies will advance foundational knowledge of cognition- and memory- related brain circuits across AD clinical stages and their links to neuropathology, and more generally, also contribute novel tools for examining dynamical causal circuits underlying human brain function and dysfunction.